A multi-level genomic and spatial analysis of MRSA transmission

Project Summary (REWRITTEN)
Community-associated methicillin-resistant S. aureus (CA-MRSA) is a major problem in urban areas, with illicit
drug use, incarceration, unstable housing, and geographic area of residence each being associated with CA-
MRSA risk. Using genomic sequencing, we have previously demonstrated that community networks may
facilitate the spread of MRSA outside of households, and epidemiologic exposures, including residence in a
high detainee release area, may serve as the basis for linkages between individuals colonized or infected with
genetically similar MRSA strains. The extent to which jails facilitate MRSA transmission, both during
incarceration and to the community at large, is unknown. Our preliminary data demonstrate a high proportion
of individuals enter the jail already colonized with MRSA and jails then provide an opportunity for at-risk
individuals to intermingle which may promote further spread of MRSA. As urban jails are characterized by high
turnover and high recidivism, we speculate the jails may be one of the major drivers of MRSA spread from and
back into urban communities. Despite the demonstrated risk associated with community settings, studies
examining infection prevention for MRSA have been conducted almost exclusively in hospitals. It is unknown if
transmission dynamics and risk factors for acquisition of MRSA in the community are the same as those that
drive transmission in hospitals. Prior studies of sexually transmitted diseases have demonstrated that
interventions in urban jails can have significant downstream benefits in the community and provide an
opportunity to intervene with a difficult-to-reach population that often lacks access to medical care. We believe
this type of intervention could be extended to MRSA and that molecular epidemiologic analysis would help to
design and maximize the benefits of a community intervention. Funds are requested to examine the genomic
epidemiology of MRSA in an urban community and to identify and characterize epicenters for MRSA spread.
We will use existing MRSA clinical cultures from 2008-2018 and integrate genomic data from these isolates
with geocoding, epidemiologic, detainee release, and US census data to test whether there are geographic
areas at highest risk for MRSA spread. We will use spatial transmission modeling to identify rates of MRSA
transmission within and between community areas and to test hypothetical interventions. The proposal has
three aims: (1) Characterize the movement of MRSA over time to identify if there is differential risk for spread
in various community areas, (2) Determine if community MRSA strains are genomically related to MRSA
strains isolated from individuals incarcerated at the jail, and (3) Identify hotspots of MRSA spread in the
community using population genomics modeling. This innovative project will be the first to track the spread of
MRSA in a large urban area, with results highlighting populations and community areas that may be the best
targets for prevention efforts. Because the study will explore well-documented disparities with CA-MRSA, our
findings will be generalizable to other underserved populations, underscoring the public health importance.

Public health relevance
Project Narrative The community-associated methicillin-resistant Staphylococcus aureus (MRSA) epidemic has significanlty impacted certain patient groups in urban areas, including individuals with incarceration eposure. The objective of this project is to examine the genomic epidemiology of MRSA in the community and identify and characterize epicenters where spread of MRSA is occurring in order to target prevention efforts.